Dominantly Inherited Alzheimer Network

Core A: Administration will serve as the Coordinating Center for the entire DIAN project. As such, the specific aims of Core A: Administration are as follows: 1. Organize and coordinate activities and communication of the Cores, subcontractors and clinical